ANTI-RETROVIRAL THERAPY OF HUMAN IMMUNODEFICIENCY VIRUS INFECTION

An intensive effort was directed toward studying the preventive and therapeutic aspects of human immunodeficiency virus (HIV) infection and the acquired immunodeficiency syndrome (AIDS). A randomized trial comparing therapy with zidovudine (ZDV) versus interferon-alpha (IFN-alpha) versus the combination in 180 patients with early HIV-1 infection completed accrual and is currently active. A dose-tolerance study of the combination of IFN-alpha and dideoxyinosine completed accrual of 53 patients and is now gathering long-term follow-up data. A randomized, double-blinded, placebo-controlled Phase II study of L-697,661 versus ZDV completed accrual of 84 patients using surrogate markers as efficacy parameters and is now undergoing final analysis. A Phase I study of N-acetyl-cysteine was begun and has enrolled 23 patients to determine the pharmacokinetics, bioavailability, maximally tolerated dose, and preliminary efficacy of this agent in the treatment of HIV-infected persons with less than 500 CD4 cells/mm3. A phase I study of CD4-Pseudomonas Exotoxin (sCD4-PE40) in HIV-infected patients was initiated and enrolled 24 patients to determine the pharmacokinetics, maximally tolerated dose, and preliminary efficacy of this agent. Follow-up analysis of a randomized, controlled, masked trial of foscarnet in the treatment of cytomegalovirus retinitis in AIDS patients demonstrated an apparent survival benefit of this therapy.